Enrichment Program

The Enrichment Program (EP) of the Indiana University (IU) Cooperative Centers of Excellence in Hematology
(CCEH) will foster interactions and promote scientific exchange among investigators and trainees involved in
NIDDK non-malignant hematology research. The program will provide forums for research training and
mentoring of students at all educational levels as well as junior faculty in the early stages of their independent
scientific careers. These include training in advances in instrumentation, computerization, and new technology
platforms at the molecular, cellular, and animal levels. Many of these advances will be offered by the
biomedical cores of the IU CCEH to young investigators and trainees nationwide involved in non-malignant
hematology research. The overall goal of the CCEH enrichment program is to pave the way for future scientific
discovery. With this goal in mind, the objective of the CCEH EP is to increase opportunities for collaboration
and provide training environments that foster enthusiasm and confidence in our students and junior faculty,
and as a consequence breed success. Our goal will be accomplished by (1) enhancing interdisciplinary
interactions amongst CCEH faculty and trainees, both within and outside IU; (2) organizing educational venues
for students at different educational levels through a combination of internships, interactive discussions, and a
CCEH Core sponsored interactive workshop; (3) Establish a travel award program to facilitate customized,
multi-tiered education and training opportunities for trainees and early phase investigators locally and
nationwide to conduct non-malignant hematology research through the IU CCEH Cores; and, (4) serve as a
national resource in the training of non-malignant hematology research that can facilitate and assist in the use
of our cores by other CCEH members and by young investigators outside IU. The EP Program will help recruit
and retain productive and talented young investigators by providing innovative impactful opportunities to
enhance training and mentoring in the field of non-malignant hematology research. The long-term outcome of
training provided by the EP will foster ground-breaking discoveries that can ultimately be applied to
development of clinical trials targeting inherited and non-inherited disorders of the hematopoietic system.

Public health relevance
Narrative N/A